The Sleep Signature: A Disentangled State in Each Neuron

For nearly a century, sleep in the brain has been defined by electrical waves that travel slowly across multiple
centimeters of the isocortex. In stark contrast, the fast neuronal spike-patterns known to encode sensory
information exist in milliseconds of microcircuit activity. My recent pre-print demonstrates that state, too, is
reliably encoded in fast, non-oscillatory spike-patterning within diverse individual microcircuits throughout the
brain. However, despite revealing a novel, fast and local foundation of sleep and wake, my initial study may
underestimate the true minimal scale of the encoding. I hypothesize that the minimal encoding of state in
neural activity is spike patterns, not at the level of the microcircuit, but the individual neuron.
First, I will verify whether individual neurons encode sleep and wake states in their spike patterns, using
previously conducted microelectrode recordings. Statistical comparisons of spike patterns betweens states will
lay a reproducible foundation in connection with prior literature. My preliminary results reveal that, while
individual neurons encode state in their activity, the general principles require further elucidation.
Generally, many encodings are structured by the hierarchical organization of the brain, and this may
also be true for sleep/wake encodings. I propose that machine learning can disentangle the general influences
of the animal and region from encodings of state that are unique to each individual neuron. Unique neuron-
level encodings in spike patterning represent a new minimal scale of state, embedding this information on the
scale of neuronal computation.
Neuron-level states could provide new insight into brain function and, specifically, animal behavior. My
recent pre-print revealed that microcircuit spiking patterns “flicker” between sleep and wake independently of
the animal’s overall state. Further, flickers emerge as a function of sleep pressure and drive behavioral
discontinuities (twitching, pausing). A new, neuron-level state encoding can reveal whether individual neurons
exhibit similar state discontinuities, and whether this explains complex interactions between state and behavior.
This work has great potential to disentangle brain states on the scale of brain computation (neurons).
Such fundamental knowledge about the basis of sleep and its connection to behavior is highly important to
public health. Biomedically, sleep dysfunction is widely implicated in nearly all neurological disorders- from
epilepsy to autism to Alzheimer’s. Further, localized forms of sleep amidst wake are increasingly observed in
conjunction with attentional disorders and stroke victims.
These aims facilitate excellent training, particularly in developing novel machine-learning architectures
and performing sophisticated electrophysiological recordings. My highly-supportive co-sponsors are excellent
investigators in computational neuroscience and sleep from renowned institutions. Completion of this proposal
will help prepare me to one day develop my own systems neuroscience research program.

Public health relevance
While sleep is typically defined by slow waves of activity extending across broad neuronal populations, recent work reveals a separate encoding in microcircuit spike patterns. This proposal investigates the hypothesis that each individual neuron’s spiking patterns represent a localized scale of sleep. Fast (<100 ms) local states are detected in single neurons and shown to explain key aspects of natural behavior.